Neural Analysis of Vocal Learning

Cortical-basal ganglia (CBG) circuits are critical for normal motor and reinforcement learning, and accordingly are a major site of psychiatric and neurological pathology, including schizophrenia and addictions. However, because of their cellular and circuit complexity, and the broad suite of behaviors they control, many basic questions about the link between neural signals in these circuits and behavior remain unanswered. Songbirds provide a powerful model in this regard, because they have a specialized CBG loop, the anterior forebrain pathway (AFP), devoted to a well-defined learned behavior, song. Recent studies in songbirds, including our own work from the last grant cycle, have suggested an important new function for CBG circuits, the active generation of behavioral variability important for learning. Consistent with this, LMAN, the 'cortical' outflow nucleus of the AFP, carries both a temporally structured signal related to song, and trial-by-trial variability around that signal. Moreover, both neural and behavioral variability can markedly decrease when birds are in a social, 'performance' context, possibly in response to midbrain dopamine (DA) release. We will now ask how and where neural variability and its underlying pattern emerge in the song network, and how the different stages of the AFP contribute to these signals and to song in both juveniles and adults, using recordings of multiple neurons in combination with behavioral and pharmacological manipulations of the AFP. Our first aim will study the first nucleus in the circuit, the striato-pallidal Area X , during both alone ('undirected') and female-directed singing, and will test possible sources of context-dependent variation by acutely blocking LMAN recurrent inputs or DA receptors. Our second aim will further test the importance of different stages of the AFP by examining LMAN activity in response to manipulations of Area X, and of its thalamic target DLM. Finally, we will test how both variability and patterned signals emerge and evolve in LMAN during learning in juvenile birds, and how they respond to social cues. The systematic dissection of circuit function possible in this system should shed light not only on normal learning, but on the many diseases of these circuits, whose symptoms often include too little or too much variability.

Public health relevance
Public Health Relevance Cortical-basal circuits are the complex site of many disabling neuropsychiatric disorders. A mechanistic understanding of how these circuits can change their signaling, and the resulting song, both in adults and during learning, in response to manipulations of social context and of different stages of the circuit, has the potential to provide new insights into dysfunction in these areas, and to suggest new treatment strategies. __SpecificAimsTextDelimiter__ Cortical-basal ganglia (CBG) circuits are critical for normal motor and reinforcement learning, and are a major site of neuropsychiatric pathology. Despite their importance, however, many basic questions about how the signals in these complex circuits relate to behavior remain unanswered. Songbirds are an informative model for such questions, because they have a specialized CBG loop, the anterior forebrain pathway (AFP), devoted to their learned vocal motor output, song - this greatly facilitates linking brain and behavior. A variety of single unit recording and behavioral studies, including our own work from the last grant cycle, reveal that LMAN, the 'cortical' outflow nucleus of the AFP, carries both a temporally structured signal related to song, and trial-by- trial variability around that signal, variability that birds can decrease when they are in a social, 'performance' context. Moreover, LMAN activity generates behavioral variability important for learning. However, to understand basal ganglia function, it is crucial to know how and where neural variability and its underlying pattern emerge in the adult song network, how these neural signals are regulated by social cues, and how they are implemented in and across the populations of neurons in the different stages of the AFP. In addition, it is critical to ask how LMAN signals in juvenile birds relate to learning. To address these questions, we are moving from single neuron recordings to simultaneous recordings of multiple single neurons and analyses of neuron-neuron/neuron-behavior correlations, in combination with behavioral and pharmacological manipulations in awake, singing birds. Our first aim will focus on the activity of multiple neurons in the striato- pallidal nucleus Area X, during alone ('undirected') and female-directed singing, and will examine the hypotheses that the neural variability seen in adult LMAN first emerges in Area X, and is regulated by dopamine (DA). Our second aim will focus on the population activity of the outflow nucleus of the network, LMAN, and will test the idea that different stages of the AFP contribute differentially to LMAN activity, by examining LMAN's response to manipulations of different steps in the circuit. Finally, in our third aim we will test the idea that variability and patterned signals emerge and evolve in LMAN during juvenile learning, and will test their link to song learning by studying how these signals and song change in response to social context. Aim 1. Test the hypothesis that the trial-by-trial variability in the activity of LMAN neurons during singing emerges within the striato-pallidal network in Area X, and examine the population mechanisms both of its emergence and of its regulation by social context. We will test several hypotheses suggested by our preliminary data and by recent work manipulating DA actions (31), including the ideas i) that an early step in generating social context-dependent LMAN signals important for learning is altered spiny neuron correlation that influences pallidal neuron pause variability, and ii) that neural variability is regulated by DA and/or by recurrent inputs from LMAN. 1A. Examine the emergence of variability in the Area X neuronal network, and the neuronal changes underlying its regulation by social context. We will record multiple neurons simultaneously in adult Area X, focusing especially on groups of spiny neurons, and of spiny and GPi neurons, to test how their firing rate and correlation change with social context. In all cases we will also assess how neural activity relates to song structure and variability. 1B. Test possible sources of variability and context-dependence of Area X signals. We will record multiple Area X neurons as in Aim 1A, and assess the effects on their firing rate, pattern, variability, and correlation, of i) acutely silencing LMAN recurrent inputs to Area X, and ii) acutely blocking DA receptors in Area X. Aim 2. Test the hypothesis that activity in Area X and in song thalamus (DLM) contribute differently to the CBG output signals in LMAN. Our preliminary data suggest that patterned bursting in LMAN depends on Area X, while aspects of singing-driven activity in LMAN do not, and likely reflect additional inputs to the AFP. 2A. Examine the changes that occur in LMAN in response to manipulations of Area X activity. We will record the activity of single and multiple neurons in adult LMAN i) after lesions of Area X, and ii) after acute DA receptor antagonism in Area X. All experiments will include both directed and undirected singing, as this alters the state of the network and allows trial-by-trial analysis of the link between AFP firing and behavior. 2B. Test the effects on LMAN firing of direct alterations of DLM activity. We will record the activity of LMAN after lesions and inactivation of DLM, and compare it to LMAN activity after Area X lesions (Aim 2A). Aim 3. Test the hypothesis that variability and patterned firing emerge and change in LMAN in relation to learning in juvenile birds, and manipulate these signals via social context. We will record from multiple LMAN neurons in juvenile birds (from 55d on) that are rapidly changing their song in response to delayed tutoring. At every stage, we will examine the rate, spiking properties, correlation across neurons, and variability of singing related activity, and its relationship to song. By recording during both undirected and directed singing, which we have shown potently change song in juveniles, we will begin to test the causal link between aspects of LMAN signals and song learning.